ACUTE SAFETY AND EFFICACY OF AEROSOLIZED NUCLEOTIDES AS THERAPY FOR CF

The purpose of this clinical research project is to explore the potential therapeutic use of naturally occurring endogenous compounds ATP and UTP as aerosol therapy for cystic fibrosis lung disease.